Improving Weight Loss Outcomes for Binge Eating Disorder

PROJECT SUMMARY/ABSTRACT
Binge eating disorder (BED) is the most prevalent eating disorder and is associated with substantial
psychiatric and medical comorbidity. Although obesity is not part of the diagnostic criteria for BED, more than
65% of individuals with BED are obese, and more than a quarter of patients seeking treatment for obesity
present with BED. To date, although there exist several effective treatments for reducing binge eating,
facilitating clinically significant weight loss in patients with BED remains a challenge. We believe the failure of
existing treatment approaches is related to 1) a lack of emphasize on altering the calorie balance (through both
diet and physical activity) without encouraging strict dietary restraint that could promote an eventual re-
occurrence of binge eating pathology, 2) limited strategies designed to promote long-term adherence to dietary
and physical activity goals, and 3) the failure of both standard behavioral weight loss treatments (SBT) and
cognitive behavioral therapy (CBT) to address key maintenance factors for BED (e.g. elevated food reward
sensitivity, overvaluation of weight and shape, negative affect and distress intolerance). Acceptance-based
behavioral treatment (ABBT) can provide individuals with the psychological tools necessary to improve
negative affect, distress intolerance, and overvaluation of weight and shape and support long-term adherence
to the dietary and physical activity recommendations designed to produce weight loss despite elevated food
reward sensitivity. Our existing pilot data support the ability of ABBTs to produce superior weight loss
outcomes both for obese patients at large and for obese patients with vulnerabilities similar to those observed
in BED. ABBTs have also been shown to effectively reduce binge eating episodes in BED. Our pilot data
suggests that ABBT could produce superior weight loss outcomes for patients with BED compared to SBT.
The primary goal of the proposed project is to evaluate the efficacy of ABBT in relation to SBT for facilitating
weight loss and weight loss maintenance in patients with BED. A secondary goal is to test hypothesized
mechanisms of action of the two treatments, both during active intervention and during the post-treatment
weight loss maintenance phase. Lastly, we aim to evaluate moderation hypotheses stating that the superiority
of ABBT will be especially pronounced for those with higher food reward sensitivity, overvaluation of weight
and shape, negative affect, and distress intolerance. Our aims work towards longer-range goals of identifying
more effective methods for improving weight loss outcomes, using evidence to maximize the effective
components of interventions, and matching patients to treatment type. Accordingly, we will randomly assign
130 overweight and obese patients with BED to 25 sessions of ABBT or SBT. All participants will be followed
until one year post-treatment. Lab-based behavioral assessments, clinician guided interventions, and self-
report measures will be used to provide a multi-method assessment of hypothesized moderating and mediating
pathways, and how these associations are affected by treatment.

Public health relevance
PROJECT NARRATIVE There is a critical need to improve weight loss outcomes for patients with binge eating disorder, a group who typically experiences sub-par weight loss and weight loss maintenance in existing behavioral treatment approaches. Current treatments do not sufficiently alter the calorie balance in a manner that is effective and suitable for patients with binge eating disorder, effectively promote long-term adherence to dietary and physical activity goals, and address relevant maintenance factors for binge eating disorder. An acceptance- based behavioral weight loss intervention that specifically targets maintenance factors relevant to both binge eating episodes and overeating episodes without loss of control could improve weight loss outcomes.